Dietary Restriction, GH/IGF-1 & Mechanisms of Cellular Protection and Regeneration

FOA: PA-20-272 Administrative Supplements to Existing NIH Grant # P01AG055369
Funded Parent Award: Dietary Restriction, GH/IGF-1 and Mechanisms of Cellular Protection and Regeneration.
Abstract
Age is the major risk factor for many morbidities including cancer, cardiovascular and neurodegenerative
diseases. Biogerontology research is well positioned to help prevent or at least delay these diseases by
identifying safe strategies to retard aging so that the degree and type of cellular damage does not reach the
threshold leading to disease incidence or progression. Here we propose to study the molecular mechanisms
linking fasting, fasting mimicking diets and protein restriction to reduced nutrient signaling, the stress resistance
signaling network, the mitochondrial peptide humanin, and in turn, cellular protection, regeneration, and
healthspan. An important advantage of the dietary interventions being tested is that they are periodic and
therefore have the potential to match and possibly surpass the beneficial effects of chronic calorie restriction
while minimizing the burden of chronic and extreme diets, but also while minimizing adverse effects.
The common goals are to: 1) identify and study novel periodic dietary interventions that promote healthspan
without causing adverse effects at old ages; 2) study the mechanisms of fasting mimicking diet- and protein
restriction-dependent cellular protection, regeneration and rejuvenation with focus on the hematopoietic and
nervous systems; 3) understand the link between dietary interventions, growth pathways and humanin to test
the hypothesis that this mitochondrial peptide functions as a healthspan modulator and determine whether it can
serve as a fasting/protein restriction mimetic.

Public health relevance
FOA: PA-20-272 Administrative Supplements to Existing NIH Grant # P01AG055369 Funded Parent Award: Dietary Restriction, GH/IGF-1 and Mechanisms of Cellular Protection and Regeneration. Project Narrative We propose to continue the collaborations between two biogerontology laboratories from the University of Southern California under the leadership of Drs. Valter Longo and Pinchas Cohen to study the molecular mechanisms linking fasting, fasting mimicking diets and protein restriction to growth genes, the stress resistance signaling network, mitochondrial biology, cellular protection, regeneration, and aging. These studies will contribute to the identification of drugs and interventions to treat and prevent multiple diseases by acting on the aging process and on multi-system regeneration and rejuvenation.